Causally linking UBE3A misexpression to altered circuit dynamics controlling skilled movements

PROJECT SUMMARY
Misregulation of the 15q11-q13 chromosomal region is particularly consequential for neurodevelopment.
Maternal copy number increases in 15q11-q13 cause duplication 15q (Dup15q) syndrome, a major subtype of
autism spectrum disorder, while maternal (but not paternal) 15q11-q13 deletions cause the neurodevelopmental
disorder Angelman syndrome (AS). There are ~20 genes in the 15q11-q13 region, but only UBE3A is expressed
exclusively from the maternal allele in mature neurons, hence it is thought to be the main genetic driver for AS
and Dup15q syndrome. Motor deficits are among the earliest and most impactful clinical phenotypes in AS and
Dup15q syndrome, although the precise manifestation differs by disorder. We currently lack an understanding
of how UBE3A misexpression alters neural circuit dynamics to impair movement control. Here we will test the
central hypothesis that the motor phenotypes resulting from UBE3A misexpression are caused by altered
dynamics in specific neural circuits. We will use mouse models to identify the impact of varying Ube3a copy
number on motor brain networks during the acquisition and production of a skilled reach-to-grasp movement that
requires planning, action sequencing, sensory-guided corrections, and adaptation. Accordingly, this project will
identify rules that govern the complex relationship between Ube3a gene dosage, motor deficits, and distributed
brain network formation and function. Finally, we will test a translationally relevant gene therapy to normalize
UBE3A expression in relevant motor circuits and restore typical motor function. Towards these goals, we will
complete three aims: (1) establish the impact of Ube3a copy number on skilled movements, (2) establish the
impact of Ube3a copy number on distributed neuronal dynamics, and (3) causally link circuit-specific
normalization of UBE3A expression to neural dynamics and skilled movements. The successful completion of
these aims is expected to guide the development of safe and efficacious therapeutic approaches for ameliorating
motor deficits in Angelman and Dup15q syndromes.

Public health relevance
PROJECT NARRATIVE There are currently no treatments for motor deficits in Angelman syndrome and Dup15q syndrome, two neurodevelopmental disorders caused, respectively, by decreases or increases in UBE3A gene copy number. This lack of treatment stems in part from a lack of insight into the etiology of the observed motor deficits. Towards developing a transformative treatment for the motor deficits in Angelman and Dup15q syndromes, in this project we will establish how changes in UBE3A gene copy number impact distributed neural circuits that control skilled movements and determine the efficacy of a novel genetic therapy approach to normalize UBE3A expression in specific, relevant neural circuits and restore typical motor function.